What do Pex4 and Pex22 do in apicomplexan membrane transport?

Project Summary
Apicomplexan parasites have major impacts on human health e.g. Plasmodium falciparum causes malaria
whereas Toxoplasma gondii causes opportunistic infections. The pathology of all apicomplexan-caused
diseases resides in lytic replication cycles and/or the ensuing immune response. Lytic replication requires
parasite invasion of an appropriate host cell, which is an essential step for their successful infection. Apicomplexa
harbor a constellation of apically localized cytoskeletal and secretory organelles dedicated to host cell invasion.
Biogenesis of and protein targeting to the three secretory organelles (micronemes, rhoptries, dense granules)
relies on the secretory pathway, but so do other organelles like the apicoplast and the inner membrane complex
(IMC). To correctly target vesicles and proteins to each of these destinations the parasite employs, like all
eukaryotes, the ‘classic’ endoplasmic reticulum (ER) and Golgi apparatus, relying on Rab GTPases and SNARE
proteins. However, in the diversified, latter half of trafficking, the Apicomplexa have repurposed aspects of the
endosomal pathway, which is still mired with questions. In this proposal, the research team proposes to probe
into the function of two peroxisome derived proteins, Pex4 and Pex22, that are universally conserved across
Apicomplexa (most Apicomplexa completely lost all other peroxisome genes). Moreover, Pex4 and 22 are
essential in the pathogenic stages of P. falciparum and T. gondii, while humans actually lost these two
peroxisome genes. Pex4 is an E2 ubiquitin-conjugating (UBC) enzyme in complex with Pex22 that functions as
a membrane anchor. In peroxisomes, they mediate cargo receptor recycling for the import of fully folded, co-
factor bound proteins (complexes) from the cytoplasm. Clearly, this defines a unique set of proteins. However,
the orthologous cargo receptor (Pex5) is missing in Apicomplexa and it is unclear on which organelle or set of
proteins Pex4/22 act. The research team proposes to address these questions in T. gondii tachyzoites, for which
powerful genetic and cell biological tools to dissect the secretory pathway are available. Presented preliminary
data put Pex4/22 in the secretory way and depletion shows severe impacts on parasite fitness. The presented
research plan will define the exact nature of where the Pex4/22 complex resides and how it acts. Conditional
knock-downs will be paired with available compartment-specific markers to determine localization and
functionality in the secretory pathway, while genetic complementation with mutant alleles will assess whether
enzymatic activity and/or complex membrane anchoring is required. Furthermore, to identify the molecular
context of the Pex4/22 process, TurboID complemented by organelle purification plus mass spectrometry will be
performed. A sub-set of prioritized candidates will be experimentally validated to cement the nature and
mechanism of the Pex4/22 complex in the apicomplexan secretory pathway. It is anticipated that Pex4/22
uniquely cater to an as yet unknown aspect of apicomplexan biology, and that the discoveries will write new
chapters in both apicomplexan AND peroxisome biology.

Public health relevance
Project Narrative Apicomplexan parasites have major impacts on human health e.g. Plasmodium falciparum causes malaria whereas Toxoplasma gondii and Babesia spp. cause opportunistic infections. At the heart of all apicomplexan pathogenesis lie repetitive lytic replication cycles, which require host cell invasion mediated by a set of uniquely dedicated secretory organelles (one of the defining features of the Apicomplexa). Although most Apicomplexa lost peroxisomes, Pex4 and Pex22 genes have been universally retained, are essential, and will be functionally dissected here to assess potential as a specific (humans lack Pex4 and 22), new drug target.